Combined Engineering and Orthopaedics Training Program

The goals of the Hospital for Special Surgery (HSS) Combined Engineering and Orthopaedics Training
Program are to identify, train, and empower a select group of high potential investigators to utilize the
principles of engineering to advance patient care through interdisciplinary research while nurturing them to
become successful academic and clinical leaders in the musculoskeletal and orthopaedic sciences. These
goals will be achieved by: (i) carefully selecting exceptional and highly motivated pre-doctoral and post-
doctoral trainees, (ii) providing them with unique training, mentoring, and research opportunities adapted to a
sub-specialty academic hospital, and (ii) placing an emphasis on interdisciplinary approaches and focused
mentoring to address clinically relevant research problems. Applications to fill two pre-doctoral positions will be
invited from diverse graduate students in the School of Engineering at Cornell University. Trainee selection is
based on outstanding performance in an existing mandatory summer ‘immersion’ term at HSS, a strong
supporting letter by an HSS-based clinical collaborator, and a commitment to spend a minimum of one full
semester at HSS. Applications for two post-doctoral positions will be invited from: (i) high caliber and diverse
residents identified by HSS Clinical Service Chiefs and the Training Program Executive Steering Committee as
rising-stars capable of pursuing clinician-scientist career pathways, and (ii) PhD post-doctoral fellows who have
demonstrated exemplary potential through prior grant support, highly cited peer-reviewed publications, and
strong cross-disciplinary collaborations. Additional key selection criteria for all positions are strong research
plans that meet the mission of the Training Program, a desire to pursue an academic career, and a strong
preceptor. A key strength to the training program is the central and unifying 40+ year relationship between
HSS and the School of Engineering at Cornell University. This relationship has been recently reorganized into
a revitalized cross-institutional center: CAMEO (Center for Advanced Materials and Engineering in
Orthopaedics) from which Training Program preceptors are drawn. Preceptors include scientists and clinician-
scientists with strong track records of conducting federally-funded research applying engineering principles
aimed at improving patient care through basic and translational research. Trainees benefit from a strong
mentoring program and a dedicated Mentorship Committee, extensive core services, expanded capabilities in
epidemiology and biostatistics, institutional patient registries, and newly created Regenerative Medicine and
Genomics Research Centers that traverse our research and clinical departments. A 10+ year collaboration with
Weill Cornell Medicine (WCM), and especially the WCM Clinical and Translational Science Center (CTSC),
provides formal coursework, seminars and symposia. In summary, our rich resources will be leveraged and
choreographed across our pre- and post-doctoral Training Program to provide a unique training experience
and position our trainees to develop successful independent careers in the orthopaedic sciences.

Public health relevance
The Combined Engineering and Orthopaedics Training Program educates, supports, and empowers exceptional pre-doctoral and post-doctoral trainees to excel in careers that apply the principles of engineering to maintain and restore musculoskeletal function. The emphasis is on developing well-rounded scientists and clinician-scientists who will leverage cross-disciplinary collaborations, cross-institutional resources, and comprehensive mentoring to develop successful independent careers in the orthopaedic sciences.